HD2A RASC-Administrative Core

ADMINISTRATIVE CORE: PROJECT SUMMARY/ABSTRACT
The Administrative Core of the HD2A Research Adoption Support Center (RASC) will host an efficient
centralized home for the HD2A Program. It will provide the necessary infrastructure, operational and logistical
support, and foster welcoming, productive and positive relationships within and across the RASC Cores and
throughout the HD2A. With strong administrative and scientific leadership, RASC’s Administrative Core will
design, develop, maintain and update user-friendly accessible platforms for HD2A grantees and the public.
Robust online tools and resources will provide the field with the best of dissemination and implementation
(D&I) methods and measures to maximize adoption of evidence-based substance use and pain interventions.
Moreover, as the heart of the RASC, the Administrative Core will strive to foster a culture of HD2A community.
The Administrative Core is the organizing hub of all RASC logistics and resources. It provides a coordination
and collaboration infrastructure for the entire HEAL D2A Program. It is engineered to: ASSESS, adapt and
respond to the needs of the Innovation Projects, the RASC Substance Use Disorder Implementation Support
(SUD-IS), Pain Implementation Support (Pain-IS), and Research & Evaluation (R&E) cores, as well as the
broader HEAL D2A Program; ASSIST with project management, coordination, and collaboration; ADVANCE
practical, meaningful, widespread and long-range impact, by leveraging innovative, high-quality and accessible
D&I resource materials. As the “grease and glue” for the RASC, the Administrative Core is the structural
foundation for day-to-day work, technical support, research synergy, and efficiency--always striving toward the
goal of high-profile impact. We aim to ignite expansive impacts throughout the fields of substance use disorder
and pain intervention research. Leadership of the Administration Core has extensive experience managing a
national implementation support network (the SAMHSA Technology Transfer Centers [ATTC; MHTTC]), an
established resource upon which the RASC elaborates, expands and advances with state-of-the science D&I
methods, measures, and a deep roster of individuals with translational research and practice expertise. As with
the other cores and the overall RASC, the Administrative Core will be dedicated to at the very least meeting
the needs and advancing the D&I impact of the HD2A program, but our ultimate goal is to change the field in
order make evidence-based interventions for pain and substance use disorders readily and equitably available.